Core A: Administration

Abstract:
This administrative core supports a proposed U19 program entitled “Integrated Research Center for Human Pain
Tissues” (INTERCEPT Pain), in which we leverage the world-class genomics and computational assets of the
McDonnell Genome Institute here at Washington University and substantial institutional strengths in
neurobiology of pain, axon degeneration and regeneration, and genetics in a coordinated program to develop
foundational new knowledge regarding the transcriptional and functional properties of tissues and cells involved
in pain transduction, transmission and modulation in humans. The Administrative Core will provide logistical
support for all projects, will oversee allocation of resources from cores B and C to the projects, will coordinate
and support regular meetings between the project teams and the annual program review. The administrative
core will also coordinate and track preparation of regular progress reports, manuscripts, and conference
abstracts and presentations. Core A will also oversee the Educational Enrichment Program, which will include a
visiting lecturer series as well as the development of a summer research opportunity for undergraduate and
medical students to take part in this critically important area of research on pain.